Complementopathies: biology, biomarkers, and targets

The overall goal of this competitive renewal is to define the biology of antiphospholipid antibody syndrome,
catastrophic antiphospholipid antibody syndrome and severe forms of COVID-19, and to discover novel
biomarkers and therapeutic targets. Complementopathies are diseases where end-organ damage is driven by
failure to regulate complement on host cells and complement inhibition mitigates cellular and end-organ damage.
Classic examples include paroxysmal nocturnal hemoglobinuria (PNH), atypical hemolytic uremic syndrome
(ahUS), and cold agglutinin disease (CAD). Complementopathies are frequently triggered by inflammation and
are often associated with a severe thrombotic phenotype, often in the microcirculation. A hallmark is the presence
of microthrombi in venules and arterioles due to endothelial injury (thrombotic microangiopathy). Our previously
funded submission entitled, Complementopathies: genotype and phenotype, led to a number of seminal
discoveries. We validated and refined a cell-based assay (modified Ham test, mHam) that measures complement
regulation on human cells, and established the HELLP (hemolysis elevated liver function tests and low platelets)
syndrome, antiphospholipid antibody syndrome (APS), catastrophic antiphospholipid antibody syndrome
(CAPS), and most recently, severe COVID-19 as complementopathies. The mHam was validated because
diseases with a positive mHam were found to have and increase in germline mutations in complement regulatory
genes (aHUS, HELLP), an antibody or protein that activates complement (anti-β2-GPI antibodies, COVID-19) or
both a germline mutation and an antibody (CAPS). Furthermore, we were able to change standard of care for
aHUS by demonstrating that terminal inhibition can be discontinued in most aHUS patients. This proposal is a
natural extension of our previously funded work and seeks to extend this work by addressing many unresolved
questions in the field. Specifically, we will: 1) develop more reliable biomarkers for APS/CAPS by defining which
APS autoantibodies activate complement; 2) identify APS patients who may not require lifelong anticoagulation;
3) prove that germline mutations in complement regulatory genes are common in CAPS; 4) prove that end-organ
damage/microvascular thrombosis/endothelial damage from SARS-CoV-2 infection is due to unregulated activity
of complement; and 5) demonstrate that germline mutations in complement regulatory genes are more common
in patients with more severe forms of COVID19. If funded, we expect to translate our findings into clinical trials
that lead to approved drugs for the treatment of severe APS/CAPS, and COVID19.

Public health relevance
The purpose of this laboratory-based proposal is to improve the diagnosis and treatment of complement-driven hematologic diseases (antiphospholipid antibody syndrome, catastrophic antiphospholipid antibody syndrome and severe COVID-19. Specifically, to define the biology and identify novel biomarkers and therapeutic targets for these disorders. Our ultimate goal is to translate our findings into clinical trials that lead to approved drugs for the treatment of severe APS/CAPS, and COVID19.